Investigating the Impact of Cognition on Capacity in Multiple Sclerosis

Project Summary/Abstract
The purpose of this K23 application is to further Dr. Adam Gerstenecker's academic research career in
multiple sclerosis (MS) investigating cognitive impairment, financial and medical decisional capacity, and brain
imaging. The candidate is a neuropsychologist whose long-term career goal is to develop a rehabilitation
program for people who are at particular risk for financial and medical capacity compromise. The study of
financial and medical decision-making capacity appears to have particular relevance in MS. For example,
50%-
75% of people with MS are no longer working a decade after diagnosis; thus, economic hardship and financial
issues become imminent challenges in the lives of those with MS. As a result, budgets must be further
stretched and investment planning retooled and reprioritized. These individuals also confront new questions
regarding medical treatments while choosing among non-curative therapies that are associated with varying
side effects. However, up to 65% of people with MS have cognitive impairment which can negatively affect
their ability to make sound medical decisions. At present, there is only one published study examining capacity
in MS and it has a number of limitations. In regards to neuroimaging, although previous studies have shown
that diffusion imaging (DI) metrics are correlated with cognitive dysfunction in MS, studies examining the
association between DI metrics and financial or medical capacity in MS are not available.
The objective of this K23 application is to investigate financial and medical capacity in MS and to examine
their clinical and neuroanatomic correlates. This project will provide preliminary data for future intervention
studies in financial and medical capacity that will be the topic of a future R01 grant proposal. The specific
research aims are to: (1) examine differences in financial and medical capacity between MS, TBI, and healthy
controls; (2) examine the neurocognitive, demographic, and disease correlates of capacity in relapsing-
remitting and progressive MS; and (3) establish correlations between DI metrics and capacity in MS. In
addition, a number of mediational and moderational analyses will be conducted. This K23 will provide the
essential training, protected time, and research data to ensure successful transition to independence including:
(1) developing increased knowledge about the course, treatment, and clinical presentation of MS; (2)
developing increased knowledge about legal and ethical issues in decision-making capacity and to gain
increased proficiency in capacity-related grantsmanship; (3) gaining increased knowledge in neuroimaging
procedures and the processing of neuroimaging data; (4) gaining increased knowledge in intervention research
and design, with a focus on the development of tailored cognitive rehabilitation; and (5) receiving increased
training in advanced statistical methods. The mentorship team is led by Dr. Khurram Bashir, an internationally
recognized expert, mentor, and scientist in MS with an outstanding mentoring track record.

Public health relevance
Project Narrative At a time in which increased cognitive ability is needed to make complex financial and medical decisions, people with MS are often experiencing cognitive decline; surprisingly though, research into the ability of people with MS to make complex financial and medical decisions is rare. This study proposes to investigate financial and medical decisional capacity and its clinical and neuroanatomical correlates in people with relapsing- remitting MS and progressive MS. The ultimate value of this research will be to act as a necessary first-step in the development of a targeted capacity rehabilitation program for people diagnosed with MS.